Building next-generation sequencing (NGS) capacity for One Health and antimicrobial stewardship projects An on-going case study of multidrug-resistant Salmonella in zoo mammals

SUMMARY
The overall goal of this project is to build next-generation sequencing (NGS) capacity
that will support One Health and antimicrobial stewardship. Currently, the NDSU VDL along
with multiple partners representing North Dakota zoos, human health lab, CDC, FDA, Vet-LIRN,
NVSL, and USDA are investigating a multidrug-resistant (MDR) Salmonella serovar Newport in
zoo mammals that clusters with a known human pathogenic strain, REPJJP01, making it a One
Health issue. Implementation of the MIRO CANVAS would allow the NDSU VDL to more rapidly
and cost effectively prepare NGS libraries for sequencing rather than waiting to batch samples.
Additionally, the MIRO CANVAS coupled with a laptop, small sequencer, portable power supply,
pipettes, minimal supplies, and small cooler bag could provide a SLAB, or Sequencing Lab-in-
A-Bag, that could be extremely versatile and deployable in the field or point-of-care site. A
zoological facility has agreed to help in the proof-of-concept of the SLAB. This equipment
proposal has two specific aims. 1) Purchase and implement a MIRO CANVAS digital
microfluidics platform for walk-away next-generation sequencing (NGS) library preparation to
sequence bacterial and viral pathogens, especially Salmonella isolates. 2) Prepare a portable
sequencing lab-in-a-bag or “SLAB” that can be deployed to the field or point-of-care site to
detect and identify potential pathogens relatively rapidly and on-site.

Public health relevance
NARRATIVE The equipment from this project will enhance the NDSU VDL’s next-generation sequencing (NGS) capacity to support One Health and antimicrobial stewardship by implementing an easy to use, low-throughput digital microfluidics NGS library preparation system (MIRO CANVAS) that can be deployed outside the laboratory with a ‘portable’ sequencer and minimal equipment for pathogen detection, discovery, and identification. Due to the time and costs associated with NGS, it is not uncommon to save and batch samples for sequencing to justify the time and consumable costs; however, this is not ideal when timing is important for treatment of a sick animal or in the case of emerging pathogens or outbreaks. The walk-away use, low-throughput capacity, and portability make the MIRO CANVAS a very useful tool that will allow the NDSU VDL to quickly prepare and sequence pathogens of One Health importance such as Salmonella in addition to other pathogens and zoonoses that may also enhance antimicrobial stewardship through detection and monitoring of antimicrobial resistance genes.